Seattle Children's Shared Light Sheet Microscopy Facility

PROJECT SUMMARY
The goal of this application is to provide biomedical researchers at the Seattle Children’s Research Institute
(SCRI), University of Washington (UW) and other partner institutions in the Seattle area with a new light-sheet
microscopy system (LifeCanvas Technologies SmartSPIM) to image tissue structure from whole organism
scale to microscopic resolution. The requested equipment will support a diversity of basic and translational
studies headed by leaders in their respective fields, with projects tackling neurodevelopmental disorders,
cancer biology, developmental biology, stem cells and tissue regeneration, and vascular biology. This imaging
resource will support the activities of 13 major users and 4 minor users supported by a portfolio of 24 NIH
grants, as well as funding from other federal agencies and foundations. This exciting new technology will allow
researchers to obtain broader and holistic data sets that will improve the quality of data collected and accuracy
of the results. It will allow researchers to overcome technical limitations of conventional 2-D histology, which
fails to capture the 3-D architecture of vascular networks, the localization of cellular subpopulations and
connectivity of neural circuits. Further, some projects involve the use of delicate tissue preparations or lightly
adherent cell types that will be affected by handling/processing of thin tissue sections. Our application is
supported by ample pilot data demonstrating need for the equipment and expertise in performing light-sheet
imaging and image analysis. There is strong Institutional commitment for the instrument, including state-of-
the-art imaging space, coverage of service contracts, maintenance personnel effort in at least the first 5 years,
backed-up data storage, and 3-D image analysis resources. This imaging resource would immediately
influence the productivity and innovation of ongoing work and will be critical in furthering the long-range
objectives of the biomedical community at SCRI and in the greater Seattle area.

Public health relevance
PROJECT NARRATIVE This application is to provide biomedical researchers at the Seattle Children’s Research Institute, University of Washington, and the greater Seattle area with SmartSPIM light-sheet imaging system. This state-of-the-art instrument will enable the study of diverse biological specimens across a range of spatial scales, spanning whole organisms/organs to microscopic structures. This unique imaging resource is essential to the productivity of numerous NIH-funded projects.